Interactions between aging, dietary restriction, and the gut microbiome

Project Summary/Abstract
The most prevalent diseases—including cardiovascular disease, cancer, and neurodegeneration—are
associated with advanced age. Delaying or reversing the mechanisms of aging may therefore also delay the
onset of these common and devastating diseases. One of the most promising interventions for delaying aging is
dietary restriction (DR), including fasting and caloric restriction. In many different animals, DR extends lifespan
and healthspan, but it remains incompletely understood how DR does this. One intriguing hypothesis is that the
gut microbiome plays a role. For example, transferring the microbiome from an organism on DR to a microbiome-
depleted recipient improves health in the recipient. In order to unravel the interactions between aging, DR, and
the gut microbiome, a large, longitudinal experiment was initiated in a cohort of genetically heterogeneous mice.
Genetically heterogeneous mice were used to mimic the genetic heterogeneity of humans and therefore to
increase the human relevance of the study. In this experiment, 960 mice were randomized at 6 months of age
to one of five dietary groups: control (ad libitum diet), two caloric restriction groups (20% or 40% fewer calories),
and two fasting groups (one-day fast or two-day fast). Stool samples and extensive aging-associated phenotypes
were collected every six months until death. The gut microbiome was profiled using metagenomic sequencing
of stool samples. This large and rich dataset will be used to 1) comprehensively catalog how aging and DR affect
the microbiome, and 2) to determine which benefits of DR are mediated by the microbiome. Hypotheses from
computational analysis of this dataset will be tested in a small validation experiment. Insights from this study will
contribute to the development of novel lifespan-extending therapies that are more targeted and less onerous
than lifelong DR.

Public health relevance
Project Narrative One of the most robust and reliable ways to extend an animal’s lifespan is through dietary restriction (DR), but how DR extends lifespan and healthspan remains incompletely understood. To investigate whether the gut microbiome mediates the health benefits of DR, the proposed study will analyze an experiment consisting of 960 mice monitored over their lifespans, with extensive phenotypic and microbiome characterization. Successful completion of this study will inform our understanding of how the gut microbiome is affected by aging and DR and determine which health benefits of DR are mediated by the microbiome.